Developing a PET tracer targeting myeloperoxidase activity for neurodegenerative diseases

Neuroinflammation is a key early event in the development of neurodegenerative diseases such as Alzheimer's
disease (AD) and Parkinson's disease (PD). Predominately driven by innate immunity mediated by microglia
and macrophages, aberrant activation of the neuroinflammatory response can generate oxidative stress to
directly damage neurons and axons, cause demyelination, and break down the blood-brain barrier.
Inflammation has been found in patients with early stage AD, PD, and multiple system atrophy (MSA). As such,
neuroinflammation is also emerging to be a potential treatment target. Thus, a non-invasive imaging method to
specifically and sensitively assess early damaging neuroinflammation would be able to detect incipient disease
before irreversible damage occurs, and enable monitoring of disease progression and treatment response of
current and emerging therapies. Through transcriptome profiling we have identified myeloperoxidase (MPO) to
be highly expressed by pro-inflammatory cells but not by reparative cells. MPO is a key generator of oxidative
stress and has been found to be associated with many neurological diseases. Increased number of MPO
immunoreactive cells have been found in the brains of early AD and PD patients, but not in the brains of
normal patients. As such, MPO is a treatment target for neurodegenerative diseases, and an MPO
inhibitor (verdiperstat) is currently undergoing phase 2/3 clinical trial for MSA and amyotrophic lateral
sclerosis (ALS). We and others have found that MRI agents targeting MPO (“MPO-Gd”) can detect
neuroinflammation and track the infiltration of myeloid immune cells into the CNS non-invasively. However,
MPO-Gd suffers from lower detection sensitivity inherent in the MRI technique and cannot cross the blood-
brain barrier (BBB), and is unable to detect the smaller amount of MPO activity in most neurodegenerative
diseases such as AD. To overcome these limitations, we propose to develop a PET agent that is not only more
specific and sensitive for MPO activity than current MPO imaging agents, but also capable of crossing the
BBB, to enable imaging of damaging inflammation in neurodegenerative diseases. This agent can also provide
complementary information to emerging imaging technologies that focus on cells (translocator protein imaging)
and abnormal proteins (β-amyloid, tau) in neurodegenerative diseases. Specifically, we will 1) systematically
design and screen potential PET agents for detecting MPO activity in the brain, 2) characterize and validate
candidate MPO PET agents in vivo, and 3) demonstrate utility of MPO PET imaging to identify and track
neuroinflammation in a mouse model of AD, and characterize safety elements of the optimized PET probe for
regulatory filing. The output of this research will be a novel MPO-targeting PET imaging probe with
demonstrated high efficacy and specificity, pharmacokinetic characterization, and preclinical dosimetry data to
enable rapid translation for human use. This project will directly enable near future clinical trials to test MPO
imaging in human neurodegenerative diseases and potentially other diseases in which MPO is implicated.

Public health relevance
Myeloperoxidase is a key damaging enzyme secreted in many neurodegenerative diseases, including Alzheimer's disease. The goal of this proposal is to develop and characterize a new PET imaging agent to specifically and sensitively map myeloperoxidase activity in the brain, validate this agent in a mouse model of Alzheimer's disease, and prepare for regulatory filing.